Evaluation of Di-indolylmethane supplementation to modulate tamoxifen efficacy in

DESCRIPTION (provided by applicant): In breast oncology, drug therapies, led by the introduction of tamoxifen (TAM), have resulted in significant improvements in survival in women diagnosed with estrogen receptor positive disease. Identifying strategies to further improve the clinical efficacy and/or reduce the known toxicities of these medications is an area of active clinical research. Recent analysis from the PI's K07 Career Development Award in Cancer Prevention and Population Sciences showed a significant 35% reduction in breast cancer recurrence rates in breast cancer survivors who consumed within the highest tertile of cruciferous vegetable intake, a finding unique to the women prescribed TAM. suggesting a favorable diet-drug interaction. This finding is supported by compelling experimental Evidence that diindolylmethane (DIM), an anticarcinogenic compound in cruciferous vegetables, can favorably modulate a number of biological pathways of breast cancer risk. To follow up on these findings we plan to conduct a phase II randomized, placebo-controlled, double-blind intervention trial among 170 premenopausal women taking TAM as adjuvant therapy for breast cancer. We will test the hypothesis that diindolylmethane (BioresponseTM DIM) at a dose of 150 mg/day with a.m. / p.m. dosing for 18 months will result in favorable modulation of breast density (measured using digital mammography and a novel fat-water ratio from MRI) that will be associated with favorable changes in mammary tissue. We also plan to assess women for modulation of estrogen metabolites, endoxifen levels and vaginal bleeding/ultrasound as surrogate biomarkers of efficacy or risk. Our research goal is to test the efficacy and safety of DIM in women taking TAM. This research to identify evidence- based diet-related strategies to significantly improve the efficacy or reduce toxicity of existing pharmaceuticals is an understudied area of translational research.

Public health relevance
PUBLIC HEALTH RELEVANCE: Tamoxifen therapy is used for the primary prevention of breast cancer and to reduce risk for recurrent disease. Supplementation of the diet with diindolylmethane, a naturally-occurring compound found in cruciferous vegetables, holds potential to improve the efficacy or reduce the toxicity of this medication. If effective, this combinational approach could reduce breast cancer burden for those at risk. Project Narrative Relevance Tamoxifen therapy is used for the primary prevention of breast cancer and to reduce risk for recurrent disease. Supplementation of the diet with diindolylmethane, a naturally-occurring compound found in cruciferous vegetables, holds potential to improve the efficacy or reduce the toxicity of this medication. If effective, this combinational approach could reduce breast cancer burden for those at risk. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Overall Goal: To test the effect of 3,3'-diindolylmethane (DIM) bioactive of cruciferous vegetables, in combination with tamoxifen (TAM) as a novel approach to modify breast cancer risk factors. A.1. Rationale and Significance: Estrogen receptor (ER) positive or luminal type tumors account for 60- 75% of all breast cancers and account for more breast cancer deaths than all other types of breast cancer combined1,2 ER+ disease demonstrates a slow but constant accumulation of recurrences over 10 to 20 years, ultimately surpassing recurrence and death rates in ER negative tumors3. A major class of drugs used to prevent or delay progression of ER+ disease is the select estrogen receptor modulators (SERMs), including tamoxifen (TAM). TAM efficacy is well established4 with current use primarily focused on premenopausal disease where TAM is prescribed as adjuvant therapy. TAM is effective in reducing risk of ER+ disease by 40- 50% (add refs) yet a sizable fraction of ER+ cases fail to achieve benefit. Efforts to maximize TAM efficacy5 are needed; thus our effort here to actively pursue additional approaches to enhance treatment response. Based on preliminary evidence and experimental and preclinical studies, we argue that response to TAM therapy, as assessed by favorable modulation of breast cancer risk factors, will be improved by concurrent administration of DIM. Most relevant here are the potential for DIM to modify breast density, steroid hormone metabolism and TAM-associated endometrial toxicity. To date, no prospective, randomized, placebo- controlled clinical trials have been conducted to test the hypothesis that exposure to DIM, in combination with TAM, can significantly modify breast cancer risk factors. We propose to test the novel hypothesis that DIM will demonstrate an enhanced efficacy of TAM by modulating the breast parenchyma to a 'low' density, 'low risk' state and alternatively by favorably modulating steroid hormone metabolism. In fact, DIM has been shown to act on breast cancer risk through a variety of mechanisms6,7, and thus we also propose to collect core breast biopsy tissue samples and blood for alternate hypotheses testing (e.g., COX-2, prolactin receptor, proliferation assays, AhR, inflammatory markers, oxidative stress, etc) related to this trial. A.2. Specific Aims: To test our primary hypothesis, we propose a randomized, double-blind, placebo- controlled trial among 170 premenopausal treated with TAM in which women are randomized to receive 150 mg oral DIM or Placebo for a period of 18 months. S1. Assess change in breast density from baseline to 18 months post-intervention using mammogram breast density measures and a novel, quantitative fat-water ratio breast magnetic resonance imaging (FWR-MRI). Hypothesis 1: DIM (150 mg/day for a period of 18 months) + TAM will result in a significantly greater reduction in breast density by mammogram and by FWR-MRI as compared to Placebo + TAM. S2. Evaluate the effect of 150 mg daily DIM on serum steroid hormones (estrogen, sex hormone binding globulin (SHBG)) and urinary 2-hydroxyestrone:16α-hydroxyestrone (2OHE1:16αOHE1) ratio as well as serum TAM metabolites (endoxifen) in premenopausal women treated with TAM. Hypothesis 2: DIM +TAM will demonstrate a significant decrease in serum free estradiol levels, and a significant increase in urinary 2OHE1:16αOHE1 ratio compared to TAM alone with a significant increase in TAM active metabolites as an indicator of DIM enhanced TAM metabolism. S3. Evaluate TAM-associated endometrial toxicity using self-reported vaginal bleeding and vaginal ultrasound in women receiving DIM (150 mg DIM daily for 18 months) in combination with TAM. Hypothesis 3: Among subjects treated with DIM + TAM incidence and the severity of self-reported vaginal bleeding and abnormal vaginal ultrasound will be lower than among women treated with Placebo + TAM. S4. Collect breast core biopsies (in a subset) and blood samples to explore change in mammary tissue architecture, cellularity and tissue markers and their association with breast density and to explore changes in biomarkers of disease risk (e.g. COX-2, DNA damage, inflammation, etc) pre/post treatment in both study arms. A.3. Significance/ Public Health Relevance: TAM is commonly prescribed for breast cancer treatment in premenopausal women. Direct demonstration of a greater risk modifying activity and/or reduced TAM toxicity TAM + DIM versus TAM alone using pharmacologic dosing of the bioavailable BioResponse" DIM would substantiate the clinical potential of DIM to improve health outcomes in this at-risk group.